Biometrics

BIOMETRICS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Biometrics shared resource of the Rutgers Cancer Institute of New Jersey (CINJ) is a Cancer Center
managed shared resource whose purpose is to provide statistical support for CINJ members in the areas of
basic, clinical, and population research.
Most CINJ members in the basic, clinical and population sciences require biostatistical expertise beyond that
acquired within their field of scientific training. The Biometrics shared resource (Biometrics) ensures that the
scientific rigor of CINJ studies is supported by outstanding, centralized and cost-effective biostatistical support.
Under the leadership of Dr. Weichung (Joe) Shih, Biometrics supports the design, conduct, analysis, and
reporting of laboratory, clinical and population research. Biometrics is committed to improving the efficiency
and effectiveness of research that answers experimental and observational questions in as short a time as
possible with the least number of subjects or samples to improve scientific efficiency, while preserving an
appropriate error rate and power.